MAP4K3 regulation of cellular stress response pathways in health and disease

Regulation of cellular metabolic status is determined by the mTORC1 complex, which senses systemic nutrient
levels and intracellular nutrients. We set out to define the signaling pathways controlling autophagy activation,
and discovered that MAP4K3 phosphorylation of transcription factor EB (TFEB) dictates autophagy status in
the cell, and documented that MAP4K3 autophagy regulation lies upstream of mTORC1 autophagy regulation.
MAP4K3 activates mTORC1 when amino acids are plentiful, but the basis for this regulation is ill-defined.
During the current funding cycle, we delineated the MAP4K3 – mTORC1 signaling pathway, linking MAP4K3
activation of mTORC1 to inhibition of AMP-activated protein kinase. Our findings reveal MAP4K3 inhibition of
AMPK may occur via phosphorylation of Sirtuin-1 resulting in LKB1 inactivation. To understand the scope of
MAP4K3 function, we completed an interactome and phosphoproteomics analysis, and implicated MAP4K3 in
regulation of the GATOR1/2 complex, which controls mTORC1 localization to the lysosome, a prerequisite step
for mTORC1 activation. We also determined that MAP4K3 can localize to the nucleus, and may participate in
the DNA damage response. All these findings indicate that MAP4K3 is a central node for the regulation of
cellular homeostasis, serving as a nexus for cross-talk between pathways of metabolism, cell stress,
and cell survival. We have begun to examine the physiological relevance of MAP4K3 phosphoregulation by
deriving lines of mice with phosphoresistant and phosphomimetic amino acid substitutions at the TFEB serine
residue (S3) subject to MAP4K3 phosphorylation. As mTORC1 dysregulation is implicated in cancer and
neurological disease, our results suggest that one appealing therapeutic strategy for diseases of altered mTOR
signaling function would be to develop drugs to inhibit MAP4K3. To achieve this goal, we performed in silico
screening for small molecules that interfere with MAP4K3 open pocket dimerization, and evaluated 13
compounds in a series of secondary and tertiary assays, identifying three promising hits. In this renewal
project, we will define components of the MAP4K3 amino acid sensing dependent pathway of mTORC1
activation and delineate the molecular basis for MAP4K3 regulation of mTORC1 activation, focusing on Sirtuin-
1 phosphoregulation by MAP4K3 and the nature of MAP4K3 interaction with the GATOR1/2 complex. We
propose to assess MAP4K3 regulation of autophagy and cell stress by carefully characterizing phenotypes and
autophagy function in TFEB S3A and S3E mice, and determining if MAP4K3 is involved in modulating DNA
damage responses. We will build on our MAP4K3 inhibitor translational drug discovery work by honing in on
the most promising lead compounds through structure-activity relationship generation of a compound series,
coupled with an independent in silico screen and kinase inhibitor potency testing followed by a critical path of
validation assays, and we will test if our lead MAP4K3 inhibitor(s) can rescue disease phenotypes in a mouse
model of tuberous sclerosis complex (TSC) and in frontotemporal dementia / tauopathy Tsc1 +/- mice .

Public health relevance
During the prior funding period, we studied the signaling pathways responsible for dictating the metabolic status of the cell, and discovered that MAP4K3 is a central node for the regulation of cellular homeostasis, serving as a key nexus for cross-talk between pathways of metabolism, cell stress, and cell survival by documenting that MAP4K3 regulates autophagy upstream of mTORC1 and by delineating the pathway by which MAP4K3 activates mTORC1 at the surface of the lysosome. Based upon unbiased interactome and phosphoproteomics analysis, we have gained a deeper understanding of the potential regulatory roles for MAP4K3, and wish to fully elucidate MAP4K3 signaling pathways converging on mTORC1 and to determine the physiological relevance of MAP4K3 function and phosphoregulation through characterization of various mouse models that we have generated. We also predict that MAP4K3 is a viable target for the treatment of cancer and neurological disease, and through in silico screening, we have identified small molecules that inhibit MAP4K3 by blocking its dimerization, and will pursue further translational drug discovery studies aimed at uncovering lead compounds to be tested in mouse model of neurological diseases caused by mTORC1 hyperactivation, focusing on tuberous sclerosis and frontotemporal dementia / tauopathy.